Center for Dissemination and Implementation At Stanford (C-DIAS): Administrative Core

C-DIAS ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The Center for Dissemination and Implementation At Stanford (C-DIAS) Administrative Core will
oversee and nurture a physical and interpersonal environment to build technical capacity, enhance scientific
innovation, and impact public health. The Administrative Core is the organizing hub of all C-DIAS logistics and
resources. It is engineered to: PREPARE the field for advanced dissemination and implementation (D&I)
research in addiction treatment services; IMPLEMENT operational efficiency and research synergy; and
SUSTAIN a longstanding, far reaching and meaningful impact.
Mark McGovern (PI) is the director of C-DIAS and the Administrative Core. He will be supported by a Center
Manager, and three research assistants with specialization in communications, technology, or data and
analytics repectively. McGovern, with two Research Core Co-Directors and one Policy & Financing Lead, serve
as the C-DIAS Internal Advisory Committee. An External Advisory Board, composed of eight accomplished and
diverse individuals, with wide ranging expertise, provide high-level guidance, challenge the status quo, and
promote national, broad-based advocacy for the C-DIAS mission.
There is no dedicated center of excellence for D&I science in addiction. In response, C-DIAS offers the
Training Education & Consultation (TEC) Services, hosted and operated by the Administrative Core. Based on
one’s research interest and goals, the TEC offers five stratified types of knowledge acquisition and career
development activities: 1) Certificate Program in D&I Science in Addiction (with 2 tracks: Research; Learning
Health Systems); 2) Small group and individual mentoring; 3) Expert consultation; 4) Virtual Grand Rounds;
and, 5) Pre-conference workshops. With lean managerial and team-based operational processes, the
Administrative Core fosters synergy among C-DIAS members across all activities. This Core provides the
vehicle for cultivating rich and rewarding relationships leading to measurable collaborations, accelerating the
progression of science, and extending well beyond the typical impact of research conducted independently.
The Administrative Core will also monitor productivity and efficient resource utilization.
C-DIAS findings, tools and resources are designed to reach the broadest possible audience, with
communications and technology platforms easily accessible and free to both scientific and non-scientific
communities. By providing fully integrated administrative services for the management, logistics,
communications, coordination, technology platforms, research, and financial administration of C-DIAS, in
addition to centralizing resources and housing the Training Education & Consultation Services, the
Administrative Core provides the structural foundation for inspired scholarly excellence, research synergy, and
efficiency. Based at Stanford, C-DIAS will serve as an open national resource, a center without walls,
accessible to all.